Internet-delivered mindfulness training to reduce cognitive variability in adults with subjective cognitive decline

PROJECT SUMMARY
Rising prevalence rates of Alzheimer’s disease (AD), paired with limited treatment options to alter the disease
course, have prompted substantial scientific investigation into delineating and prolonging preclinical stages of
AD. Presence of subjective cognitive decline (SCD) is the earliest detectable preclinical stage of AD, reflected
by self-reported cognitive decline in the absence of objective cognitive impairment on standardized
neuropsychological testing. People with SCD are at elevated risk of developing AD, report more variable
cognitive functioning in daily life not yet detectable on lab-based neuropsychological testing, and exhibit less
stable brain dynamics that mirror changes commonly observed in AD—making them ideal candidates for
prevention-based behavioral interventions. Thus, there is an urgent need to identify promising preventative
interventions to mitigate cognitive and neural risks associated with the development of AD for adults with SCD.
Mindfulness training is one such intervention shown to improve multiple aspects of functioning relevant to AD,
including cognitive functioning, brain structural integrity, and brain functional integrity. Building upon this prior
work, the current proposal will leverage my sponsor’s ongoing pilot feasibility trial—the Internet-based Mind-
Body Training study (iMBT; 1R61AG081982-01)—to investigate whether mindfulness training reduces
everyday cognitive variability and enhances intrinsic brain dynamics among adults with SCD. Here, I will
investigate whether an internet-delivered Mindfulness-Based Stress Reduction (iMBSR) program compared to
a Lifestyle Education (iLE) program reduces cognitive variability in daily life, as indexed by two ecological
momentary assessment cognitive tests. I will also examine the preliminary effects of iMBSR versus iLE
programs on dynamic, whole-brain states—measured using resting-state dynamic functional connectivity and
k-means clustering analysis. By using innovative methodologies, findings from this proposal will enable us to
delineate cognitive variability in everyday contexts and neural dynamics among individuals with SCD. Critically,
the proposed research will yield novel insights into the utility of mindfulness training for promoting cognitive and
neural stability in adults at-risk for AD.

Public health relevance
PROJECT NARRATIVE There is a critical need to identify behavioral interventions to promote neurocognitive stability among individuals at-risk for Alzheimer’s Disease (AD) and related dementias. The proposed research will build upon a pilot feasibility trial (1R61AG081982-01) to examine preliminary effects of an internet-delivered mindfulness training program on everyday cognitive variability and intrinsic brain dynamics in adults with subjective cognitive decline. Specifically, this proposal will assess preliminary effects of the training programs on everyday cognitive variability using ecological momentary assessment cognitive testing and on whole-brain dynamic states using resting-state dynamic functional connectivity.